Administration Core

SUMMARY: ADMINISTRATIVE CORE (AC)
The integrated approach described in the UNM Center for Native Environmental Health Equity (Native EH
Equity) will for the first time address, across multiple tribes, disparities in social determinants of health, and
tribal cultural and traditional practices with the potential to provide resilience to reduce the effects of
environmental disparities on the health of Native Americans. The Native EH Equity approach, also for the
first time, provides an integrative understanding of the generalizability of risk and resilience factors across
multiple tribes – Navajo Nation, Crow Nation, and the Cheyenne River Sioux Tribe (CRST) - to improve both
our understanding of these relationships, and our ability to develop and prioritize evidence-based risk
reduction and prevention strategies. The focus of Native EH Equity will be to develop common data sets
that for the first time will standardize our approach to assessing these variables across multiple tribes.
Achieving these goals requires a strong administrative structure to ensure consistency across all
components of the Center, to ensure parallel data are collected from each of the partner tribes, and that
data are managed in a structure that ensures integration and allows comparative analyses. The
Administrative Core (AC) for Native EH Equity brings decades of experience working with Tribal
communities, leadership, and agencies; of managing and analyzing large and complex datasets; of
oversight of career development programs; of integrative analyses allowing replication of findings with
multiple levels of data; and of successful translation of results to enhance understanding in communities,
among researchers, to federal agencies, and to health care providers. The goal of the Administrative Core
(AC) is to facilitate responsible management, resource allocation, integration and communication within the
team; to foster successful career development for new investigators; to provide and manage pilot funding;
and long-term to develop sustainable partnerships integrated within the institutional and tribal structures to
ensure sustainability of research on Native Environmental Health Equity.